Improving HIV testing, linkage, and retention in care for men through U=U messaging

PROJECT ABSTRACT

Increasing the coverage of HIV testing and treatment among people living with HIV is essential for ending the global AIDS epidemic. Unfortunately, men living with HIV are less likely to know their HIV status, start anti-retroviral treatment, or achieve viral suppression. Given that new HIV infections are driven, in part, by men’s testing and treatment gaps, reducing this gap in testing uptake, treatment initiation and achievement of viral suppression by men must be prioritized in order to accelerate the decline in HIV incidence among all people, improve men’s HIV-related health outcomes and achieve the UNAIDS 95-95-95 goals by 2030. In this study, we evaluate the effectiveness of Undetectable Equals Untransmittable or “U=U” messaging for closing men’s gaps in the HIV cascade. The U=U message communicates the compelling idea that people living with HIV who take anti-retroviral therepy and have an undetectable viral load (<200 copies/mL) cannot sexually transmit HIV. Particularly for men, the U=U message has the potential to accelerate progress towards the 95-95-95 targets by: 1) reducing anxiety associated with HIV testing (1st 95); 2) encouraging people who test HIV-positive to initiate ART (2nd 95); and 3) reducing fear of transmitting HIV to sexual partners by promoting treatment adherence to achieve viral suppression (3rd 95). While there is a growing knowledge of Treatment as Prevention/U=U among people living with HIV in Western countries, the reach and penetration of the U=U message in sub-Saharan Africa has been limited and few studies have tested the impacted of accessible U=U messages on ART uptake and adherence in sub-Saharan Africa. Building on our prior work on U=U messaging informed by behavioral economics and human-centered design, we propose to conduct two hybrid type 1 effectiveness-implementation randomized controlled trials to evaluate the impact of U=U messages on men’s uptake of community-based HIV testing and treatment initiation (Aim 1), and achievement of viral suppression (Aim 2). We will also conduct a multi-method evaluation to inform future implementation of U=U messaging interventions. To improve the generalizability of our findings, we will conduct our study in two provinces in South Africa (Western and Eastern Cape). If effective, our intervention can shape global HIV testing and treatment counselling guidelines and practices. Our expert, multi-institutional collaborations will allow us to apply previous research findings, leverage unique implementation platforms and resources, and rapidly disseminate our findings.

Public health relevance
PROJECT NARRATIVE Men living with HIV are significantly less likely to know their HIV status, initiate anti-retroviral therapy, and achieve viral suppression, particularly in South Africa. Furthermore, while there is growing knowledge of the Undetectable Equals Untransmittable (U=U) concepts in Western and high-income countries, the reach and penetration of the U=U message in sub-Saharan Africa has been limited. Our rigorous evaluation of interventions that incorporate U=U messages for men in a high HIV prevalence setting will provide critical information to inform the implementation of HIV testing and anti-retroviral therapy adherence counseling guidelines in South Africa and globally, ultimately accelerating the decline in HIV incidence among all people, improving men's HIV-related health outcomes, and improving the likelihood of achieving United Nations Programme on HIV/AIDS 95-95-95 goals by 2030.